Midcareer award in aging-related subspecialty research

Project Summary Abstract
Career Objectives: My long-term career goals are to conduct research that understands how digital health
tools can be used to improve care of older adults, to understand aging-specific barriers to these tools, and to
become an exceptional mentor for junior scientists. My short-term objectives during the award period, which
will help me to reach these goals, are as follows: (1) To gain further expertise in digital app development, with
a focus on measuring aging-related impairments; (2) To implement a junior faculty training program that
focuses on understanding risk for older patients in the medical and surgical subspecialties; (3) To become a
national leader in research at the intersection of geriatrics and digital health. To achieve my objectives I will
complete a structured program of career development that will strengthen my own research skills and my
ability to mentor others. I have assembled a team of faculty for my career training with expertise in geriatrics,
computer science, and geriatric cardiology. I will meet with these experts on a regular basis and in parallel will
pursue structured coursework and attendance at national scientific meetings. Mentoring Plan: I have
mentored over 20 trainees to date and will have 4 junior faculty mentees at the start of the award, all of whom
hold (or will soon be applying for) extramural funding. My mentees will complete a training program that
includes both formal didactics and regular 1:1 meetings with me in order to monitor progress. I will also identify
new trainees during the award period through several methods, including the NYU Cardiology Fellowship
Program (where I serve as core faculty), the NYU Department of Population Health, and national professional
societies where I have been involved in several geriatrics-focused committees. Research Plan: The proposed
research for this award aligns with my career development activities and will provide opportunities for mentees.
Our research plan focuses on use of the GeriKit app, a geriatric assessment tool that was developed through
NYU’s Geriatric Cardiology Program and is available for free on Apple’s iOS and Google’s Android operating
systems. We will first test GeriKit on a sample of 150 older adults (age ≥75) with ischemic heart disease to
evaluate whether the burden of measured impairments predicts readmission and mortality (primary composite
outcome) as well as health status (secondary outcome) (Aim 1). We will then convene a group of expert faculty
to add the domains of delirium, hearing impairment, and vision impairment to GeriKit, and will test functionality
on 20 older adults (Aim 2). Finally, we will work with NYU Medical Center Information Technology (MCIT) to
integrate GeriKit with the electronic health record (EHR) so that geriatric impairments become viewable in
patients’ medical histories. This step is critical in clinicians recognizing the presence of geriatric impairments,
which may influence clinical decision making. Summary: I have a strong commitment to mentoring, and this
award will enable me to become a truly exceptional mentor who trains the next generation of clinician-scientists
focused on improving the health of older adults.

Public health relevance
Project Narrative Older adults commonly have impairments related to aging, such as issues with memory or walking, but often these aren’t measured as part of routine medical care. We created an app called GeriKit, which can be used on a mobile phone or tablet computer, to make it easier for clinicians to measure these impairments. In the proposed study we will evaluate whether GeriKit can be used to predict what happens to patients, and also add new instruments to improve the app, all of which will provide new opportunities for junior scientists who are focused on aging research.